Using Salmonella Pathogenesis and Cell Biology as a Discovery Tool

SUMMARY
The inner membrane of pathogenic Gram-negative bacteria contains lipids and proteins that are distinct from
those of mammalian cell membranes. Inner membranes therefore could be attacked by small molecules during
infection, when soluble host innate immunity damages the protective outer membrane barrier, increasing
access to chemicals. Exploration of molecules that a) interrupt pathogenesis in cell culture with minimal host
cell damage, and b) perturb inner membranes under broth conditions that permeabilize the outer membrane
has the potential to reveal whether bacterial virulence can be short-circuited by compounds that disturb inner
membranes but do not inhibit bacterial growth under standard broth conditions. An in-macrophage cell biology-
based method called SAFIRE appears to identify compounds that negatively affect bacterial inner membranes
while sparing host cell membranes. Within this application we propose to study a SAFIRE-identified compound,
D66, which appears to damage bacterial inner membranes without lysing them. Published and unpublished
preliminary data together indicate that D66 accesses bacterial inner membranes when the LPS layer is
damaged or efflux pumps are compromised, conditions consistent with the macrophage phagosome. However,
D66 disrupts inner membrane voltage rapidly and at concentrations that do not destroy the inner membrane
lipid bilayer, indicating that the compound is not causing bacterial lysis but is disturbing the membrane more
subtly. We hypothesize that D66 damages the bacterial cell membrane in a process that triggers stress
response pathways but does not cause rapid physical disruption of the lipid bilayer. We propose cell biological
and animal infection experiments to test this hypothesis.

Public health relevance
NARRATIVE This application investigates the feasibility of a new way to interrupt an intracellular infection, using a chemical that damages the bacterial inner membrane. The larger significance of these efforts is their potential to reveal new approach(es) for addressing the growing problem of untreatable bacterial infections.